Developing large language models for drug safety and effectiveness causal analysis

Project Summary
Because randomized controlled trials often severely underrepresent frail and complex patients, it is pivotal to
inform physicians’ treatment choices with drug safety and effectiveness studies based on real-world data.
Electronic health records (EHR) contain rich clinical information and are among the most commonly used real-
world data for causal effect estimation for pharmacotherapies. However, much of the essential data is embedded
in the free-text clinical notes and reports (unstructured EHR). However, the traditional natural language
processing (NLP) approaches require a labor-intensive process of knowledge acquisition and training dataset
creation for each phenotype. This makes it not scalable for the large numbers of outcome phenotypes, risk
stratification factors, and potential confounders (often>200) that need to be created for a typical
pharmacoepidemiologic study. In contrast, developing Large Language Models (LLMs) is a more scalable
approach because LLMs can be used to predict phenotypes not defined during the training stage. Yet, existing
LLMs were not tailored for determining essential phenotypes for causal effect estimation of pharmacotherapies.
Our objective is to build an LLM-based causal analytical platform for drug safety and effectiveness using two
large multi-center EHR systems linked with Centers for Medicare & Medicaid Services (CMS) utilization, clinical
assessment, and pharmacy dispensing data covering>1.3 million lives from 2000-2024. Our central working
hypothesis is that our novel LLMs have robust performance in determining a wide variety of clinical phenotypes,
including those not originally targeted during the training stage, and they can be used to reduce missing data for
pharmacoepidemiology causal analysis. In Aim 1, we will train novel LLMs for phenotypes commonly used in
drug safety and effectiveness causal analysis building on existing general-purpose LLMs. The reference
standard of the target phenotypes will be provided by large-scale annotation based on structured data in the
linked external clinical data. The targeted phenotypes include cognitive function, mental and functional status,
pain levels, mood symptoms, adherence to chronic medications, and healthcare utilization outside of study EHR.
In Aim 2, we will assess the generalizability of the novel LLMs to predict eight new categories of phenotypes (not
already targeted in Aim 1) in an independent dataset. We will further optimize the LLMs based on the
performance in the validation dataset. In Aim 3, we will determine the impact of LLM-derived features on causal
effect estimation in three categories of highly relevant empirical drug safety and effectiveness studies in terms
of bias and variance reduction. This LLM-based causal analytical platform can be used to generate a wide range
of high-validity clinical features that enable causal effect estimation with adequate patient outcome phenotyping,
confounding adjustment, and treatment effect heterogeneity evaluation, which is required for high-quality
evidence for individualized prescribing.

Public health relevance
Project narrative: The objective of this study is to build a novel large language model (LLM) based causal analytical platform for drug safety and effectiveness. It will generate a wide range of high-validity clinical features that enable causal effect estimation of pharmacotherapies with adequate patient outcome ascertainment, confounding adjustment, and subgroup effect evaluation.